Modeling Transcriptional Reprogramming by Markov Chain Monte Carlo Sampling

DESCRIPTION (provided by applicant): Complex diseases, including cancer and multiple sclerosis, arise when multiple biological systems are impacted by molecular changes, such as gene mutation, gene silencing, or cellular modification by external agents. These molecular changes lead to changes in the cellular state, almost always including reprogramming of gene expression. Because biological systems are inherently complex and nonlinear, appropriate modeling of the system is required to recover knowledge of systems-level behavior in many cases. We focus in this proposal on methods to improve our ability to infer biological process activity from high- throughput data and on the development of biomarkers of these processes. We have developed a Markov chain Monte Carlo algorithm for analysis of microarray data that combines knowledge of transcriptional regulation and simple models of signaling networks to identify on-target and off- targets effects of therapeutics in cancer. Here we propose including prior knowledge in this algorithm by integrating data from pathways, gene mutations, methylation arrays, miRNA arrays, and protein-protein interactions (PPIs) to improve inference of cell behavior at a systems-level. Our first aim will develop an integrated model of signaling coupled to transcriptional reprogramming that couples knowledge of pathways to measurements of mutation status and miRNA levels to improve estimation of cell signaling. Our second aim will integrate methylation measurements and transcription factor binding site information as prior data to refine inference of targets of transcription factors to improve gene set inference and estimation of upstream signaling. Our third aim will develop a methodology to find reliable biomarkers from our models in light of multiple regulation of genes. Successful completion of the proposed work will provide novel open-source tools for improved inference on and biomarker identification of transcriptional reprogramming of cells. This will substantially improve inference of the specific changes that drive systems out of homeostasis and of treatment response in individual cases.

Public health relevance
Project Narrative Many diseases, including cancer and many autoimmune diseases, arise from errors in signaling networks that drive aberrant transcriptional reprogramming of cells. We focus here on methods to deduce aberrant signaling activity from transcriptional data, incorporating prior biological knowledge including known pathways, mutations, methylation status, miRNA expression, and protein-protein interactions. This will improve our ability to target aberrant pathway activity on an individualized basis and to determine the targeting of therapeutics designed to restore homeostasis, enhancing personalized medicine. __SpecificAimsTextDelimiter__ Specific Aims Complex diseases, including cancer and multiple sclerosis, arise only when multiple biological systems are impacted by molecular changes, such as gene mutation, gene silencing, or cellular modification by external agents. These molecular changes lead to changes in the cellular state, almost always including reprogram- ming of gene expression. Major changes to expression typically involve transcriptional regulation, although translational control can also be modified through miRNA changes and regulation of ribosomal subunits. Because biological systems are inherently complex and nonlinear, appropriate modeling of the system is required to recover knowledge of systems-level behavior in many cases. For instance, we can distinguish between biomarkers of system state, which are useful for diagnosing a disease, and biomarkers of biolog- ical processes, which can provide data for nonlinear modeling and treatment intervention. For example, a molecule that is tied to phenotype, such as glucose levels in diabetes, provides diagnostic capability. How- ever, understanding the metabolism of glucose in order to treat the disease requires an understanding that cannot be acquired from simple statistical comparisons of measurements on two individuals with two different phenotypes. Instead, processes from enzymatic production of ATP to feedback within the insulin signaling sys- tem must be modeled. We focus in this proposal on methods to improve our ability to infer biological process activity from high-throughput data and on the development of biomarkers of these processes. Our present algorithm, developed under an NLM R21 mechanism, performs Markov chain Monte Carlo (MCMC) simulation on microarray data using knowledge of transcriptional regulation as additional informa- tion to refine identification of transcription factor (TF) activity. We have used this approach coupled to simple models of signaling networks to identify on-target and off-targets effects of targeted therapeutics in cancer cell lines and tumors, in addition to identification of biological processes active in specific tissues or in mutant cells. Here we propose extending the prior knowledge by integrating data from methylation arrays, miRNA arrays, and protein-protein interactions (PPIs) to improve models that provide prior distributions of transcrip- tional reprogramming. The new MCMC algorithm will provide a systems-level view of the cell behavior across the conditions or individuals measured. In addition, MCMC sampling will improve our biological models of interactions between biomolecules in vivo. Aim 1: Develop a model of signaling coupled to transcriptional reprogramming We will integrate core network models, such as from the Kyoto Encyclopedia of Genes and Genomes (KEGG) and Biocarta, with PPI data, as in BIND, and miRNA target prediction to provide a prior model of cell signaling linked to transcrip- tional regulators. We will encode this as prior probability distributions for MCMC simulation of transcriptional reprogramming, and analyze data from microarrays using this model to improve inference on network activity. Aim 2: Develop a model of the effect of methylation on inference of transcriptional reprogramming Methylation changes in the promoter regions of genes are known to directly modify the expression of those genes. In addition, methylation changes lead to changes in transcriptional regulatory networks and down- stream targets, which encode proteins that may play a role in cell signaling, leading to unexpected additional transcriptional modifications. We will build a model of transcriptional reprogramming that integrates methyla- tion changes and downstream effects as prior knowledge for our MCMC approach. This will permit refinement of TF activity prediction based on loss of subsets of genes from target sets as well as refinement of priors on networks based on loss of expression. Aim 3: Develop a methodology to identify biomarkers for transcriptional reprogramming based on the MCMC models Biomarkers differentiate two states, such as disease vs. normal or responsive vs. non-responsive to treatment. For biomarkers related to cell signaling and transcriptional reprogramming, we must identify biomolecules that are both strongly tied to the underlying reprogramming and not coregulated by processes outside our models. We will therefore develop a method that 1) analyzes the model parameters to identify biomolecular states that are strongly tied to the outcome of interest (e.g., signal in a pathway) and 2) identifies from large external data resources confounding behaviors for these biomolecules. Successful completion of the proposed work will provide novel open-source tools for improved inference on and biomarker identification of transcriptional reprogramming of cells. It will also lay the foundation for full integration of all data types into a comprehensive, systems-level model of biomolecular behavior in cells.